Post genome wide association studies in testicular germ cell tumors

The Testicular Cancer Consortium (TECAC) is the only international collaborative group whose goal is to
understand the genetic susceptibility to testicular germ cell tumors (TGCT). The incidence of TGCT is highest
among men of European ancestry, and the most common cancer affecting men aged 15-45. TECAC and its
members have conducted successful genome-wide association studies (GWAS) of TGCT; our latest analysis
has identified 22 novel susceptibility alleles bringing the total validated risk markers to 68, accounting for 43%
of heritability. Our studies have revealed the critical role of variation affecting essential pathways of male germ
cell development and maturation, sex determination, chromosomal segregation, and DNA maintenance in
TGCT susceptibility. We propose three complementary aims to deepen our discovery of inherited variation of
susceptibility to TGCT, results of which will refine our understanding of the biology of TGCT and male germ cell
development, provide insights into inherited variation predisposing to genomic instability, and improve our
ability to identify patients at highest risk of disease. In Aim 1, we will identify rare and common variants
(individual and gene burden) using whole exome (WES) approaches followed by independent validation. We
will conduct de novo WES on extant biosamples from 1000 and 1000 men with and without TGCT,
respectively, and assemble existing WES data from 2066 men with TGCT from TECAC members for
comparison to genomically matched (1:4) unaffected men from the Penn Medicine and UK Biobanks. To
address data heterogeneity, WES data from all sources will be called together using a common pipeline. Fifty
genes and 500 SNPs will be selected for validation in an independent set of extant biosamples from 5000 and
5000 men with and without TGCT, respectively, all with existing genome-wide genotyping. In Aim 2, we will
conduct a transcriptome-wide association study (TWAS), preceded by the largest GWAS study to date in
15,847 men with TGCT and 27,178 (230,610 with deCODE) men without TGCT. We will use a customized
version of FUSION to perform the TWAS, annotated with expression data derived from TGCT cell lines, fetal
and adult germ cells, GTEx, and single cell sequencing of germ cells. In Aim 3, after in silico assessment and
prioritization, 20 top loci/genes will be evaluated in TGCT in vitro models using siRNA and CRISPR to assess
over-expression and knockdown effects on morphology, proliferation, chromosomal abnormalities, and
cisplatin sensitivity. We will select candidate genes from our past genetic association efforts (11 preliminarily
prioritized) and from novel loci/genes found in our WES (Aim 1), GWAS and TWAS (Aim 2) efforts. Our
renewal builds upon our accomplishments and paves the way to identify novel susceptibility loci through three
highly cohesive aims. Our findings will lead to further ground-breaking insights into the biology and genetic
etiology of TGCT and will provide data needed to identify men at greatest need for surveillance, the optimal
way to decrease serious TGCT treatment-related morbidity.

Public health relevance
Testicular germ cell tumors (TGCT) are the most common tumor type in white men ages 15-45, with an increasing incidence. They have a high heritability and inherited variation underlies ~50% of the risk of the disease. We build upon our prior research in the Testicular Cancer Consortium to identify additional genetic variation associated with disease risk, so that we expand our understanding of TGCT biology and epidemiology, as well as identify the men at highest risk of disease.